Project 3: Pandemic Virus Protease Inhibitors

Project 3 – Pandemic Virus Protease Inhibitors
ABSTRACT
Viral proteases are high-priority drug targets due to their essential functions in virus replication and also
unambiguous evidence for druggability, with HIV and HCV drugs as major success stories. This project is
organized with the goal of developing novel chemical inhibitors of coronavirus and flavivirus proteases.
Specifically, SARS-CoV-2 has two proteases, Papain-Like Protease (PLPro) and Main Protease (MPro), that
catalyze 3 and 11 viral polyprotein cleavage events, respectively. SARS-CoV-2 MPro is an attractive drug target
due to the large number of essential cleavages at the earliest stages of viral infection and the fact that it has
multiple druggable surfaces, including an active site cysteine amenable to covalent adduction. It also shares
mechanistic and structural features with related coronavirus MPro proteins, which suggests that it may be possible
to develop a pan-coronavirus MPro inhibitor for use against the current pandemic virus and for future use against
future coronavirus zoonotic events. Similarly, flaviviruses such as Zika virus require protease function for the
earliest viral life cycle stages. The Zika virus NS2B-NS3 protease also has multiple druggable surfaces, and
amino acid and structural similarities with related flavivirus proteases suggest potential for broader spectrum
inhibition. As preliminary studies, we have designed and optimized multiple assays for these viral proteases,
contributed to the wealth of structural, biophysical, and computational knowledge of these drug targets, and
already obtained multiple series of candidate small molecule inhibitors. We propose two specific aims in order
to expedite the achievement of our central goal. In Aim 1, we will leverage our assays and work closely with our
screening (Core B) and structural/computational/virology cores (Cores D-E) to identify additional small molecule
inhibitors of these two enzymes in order to maximize chances of obtaining hit series for further development. In
Aim 2, candidate hits will be prioritized for further development by testing in orthologous secondary and tertiary
assays and, in close collaboration with our chemistry/DMPK and structural/computational cores (Cores C-D),
elaborated by systematically designing and testing related commercial and novel synthesized molecules. At all
stages of development, representative hits from each series will be evaluated quantitatively using cellular assays
and, in close collaboration with our virology core (Core E), also tested rigorously using the best available systems
for virus replication and pathogenesis in vivo. The major deliverable from this highly integrated and collaborative
effort will be multiple novel lead inhibitors for pre-clinical and clinical testing with industry partners with the hope
of soon-fortifying the arsenal of drugs that will be required to end the COVID-19 pandemic and help neutralize
future outbreaks.

Public health relevance
Project 3 – Pandemic Virus Protease Inhibitors NARRATIVE We have formed a highly integrated and multidisciplinary team to identify and develop chemical inhibitors of pandemic virus protease function. Backed by strong initial results with SARS-CoV-2 and Zika virus proteases, we aim to identify novel small molecules that can be developed into effective orally available drugs against these enzymes that potently and safely suppress virus replication and help prevent adverse clinical outcomes including death.